AUTOIMMUNE HEMOLYTIC ANEMIA AND EXPRESSION OF IG GENES

Identify the IgVH genes expressed by leukemia cells of patients with chronic lymphocytic leukemia and then evaluate such patients for the development of autoimmune hemolytic anemia or immune thrombocytopenic purpura.